The Project STAR Healthy Aging Experiment

The purpose of this grant is to obtain preliminary data to support a larger study that would recontact 11,240
participants of a successful multicenter randomized controlled trial of small class sizes called Project
Student/Teacher Achievement Ratio (STAR). This future study would provide critically important information on
whether changes to early childhood education can have positive impacts on healthy aging and risk factors for
Alzheimer’s Disease and Alzheimer’s Disease Related Dementias (AD/ADRD). The original study, conducted
between 1985-1989, produced higher rates of high school graduation, college attendance, earnings, home
ownership, higher savings, and lower crime among treated participants relative to control participants. Because
these are social determinants of health, we expect that it also improved participants’ health and aging and
proximate risk factors for AD/ADRD. Project STAR therefore presents one potential solution to the vexing
problem of declining health in the United States.
Project STAR is unique not only because it experimentally tests the value of small class size on education, but
also because it tests other measures of classroom quality, such as teacher experience. It therefore allows for
two experiments in one.
Our short-term objectives are to examine whether Project STAR reduced premature mortality for the
treatment group relative to the control group and to assess the feasibility of recontacting the original cohort.
Our long-term objective is to turn Project STAR into a living cohort to study the social determinants of healthy
aging by collecting laboratory and survey data, including biological age, pace of aging and proximal risk factors
for AD/ADRD. The aims of the study are: 1) to collect preliminary data for a future R01; 2) to determine
whether small class sizes reduce premature mortality in mid-adulthood; and 3) to release a dataset linking
Project STAR experimental data to prospective mortality records using NDI.

Public health relevance
PROJECT NARRATIVE Improved education in childhood is thought to improve adult health and brain function. Our grant proposal will show whether it is possible to conduct an ambitious study in which we hope to re-contact 11,240 participants in a successful education experiment that began in 1985. This will allow us to understand whether students in small size classrooms age better, have better physical health, and have better brain health than students who were in regular size classrooms.